Project 2

Our mathematical/computational Preliminary Studies emphasize the analysis of experimental data collected by our multidisciplinary team at Center of Cancer Systems Biology in conjunction with human data from the literature, to construct a predictive model of dynamic steps in carcinogenesis ? Initiation consists of one or more comparatively rapid genomic or epigenetic alterations; the alterations produce cell clones that may become dysplastic or hyperplastic and are at risk for being transformed. ? Promotion, according to one common view, involves the proliferation of initiated, and thus premalignant, cells. Promotion may take many years and the cell lineages may incur additional alterations. ? (Malignant) transformation is a further genomic or epigenetic alteration in an initiated/promoted lineage. Sometimes, transformation is considered to be one point mutation in a key gene, but other models consider larger scale DNA changes (e.g. deletions, duplications, translocations and inversions, aneuploidy, or horizontal transfer) and/or consider multiple alterations instead of just one alteration. ? Progression occurs as a malignant cell lineage evolves in interaction with its microenvironment, often becoming increasingly malignant and invasive. Genomic instability is a common feature. Many computational models implement all or part of this timeline, often with additional steps (reviewed, e.g., in [Cox & Huber 2007; Little et al. 2008a]). One basic implementation is the classic two-stage clonal expansion (TSCE) model, which emphasizes probabilistic promotion. Two-stage refers to initiation to pre-malignancy (stage 1) and transformation to malignancy (stage 2).